Leveraging antibody-omics to prevent and detect TB in children affected by HIV

ABSTRACT
One million children develop tuberculosis (TB) each year and TB is the leading cause of death among children
with HIV. Novel strategies to diagnose and prevent pediatric TB are urgently needed, but progress has been
hindered by poor sensitivity of current microbiologic and immunologic diagnostic tools, as well as an unclear
understanding of immune correlates of TB protection. We have led clinical and translational research studies to
elucidate humoral immune responses to TB in children and adults and have optimized a multiparameter high-
throughput assay to characterize detailed antigen-specific antibody Fc features that guide both innate and
adaptive TB immune responses. We propose to leverage specimen repositories from well-characterized clinical
pediatric cohorts from Kenya, South Africa, India, and a multi-center IMPAACT study to define antibody Fc
features associated with protection from Mycobacterium tuberculosis (Mtb) infection among infants with and
without maternal HIV exposure (Aim 1) and identify biomarkers for active TB and Mtb infection as compared to
Mtb-uninfected healthy controls (Aim 2). We hypothesize that an IgM-based signature detected in early infancy
will be associated with protection from Mtb infection, and that we will discover unique Mtb-specific antibody Fc
glycan profiles among children with TB disease. The results of this study will have significant public health
implications for children affected by HIV in TB-endemic settings, through advancing our knowledge of Mtb-
specific humoral immunity that can be harnessed for innovative public health strategies, including new maternal
and infant vaccines, monoclonal antibody development, and point-of-care (POC) testing for Mtb infection and
TB disease.

Public health relevance
NARRATIVE One million children develop tuberculosis (TB) each year and TB is the leading cause of death among children with HIV. Novel strategies to diagnose and prevent pediatric TB are urgently needed, but progress has been hindered by poor performance of current microbiologic and immunologic diagnostic tools, as well as an unclear understanding of immune correlates of TB protection. The proposed study will utilize specimens from unique cohorts of children with HIV infection and infants with and without HIV exposure to define prognostic and diagnostic antibody features of Mycobacterium tuberculosis (Mtb) infection and TB disease.